Generation of antibody-drug conjugates by proximity-based sortase-mediated ligation

There has been growing interest in the use of antibody drug conjugates (ADCs) for the treatment of cancer as
mounting data suggests an increase in anti-tumor effectiveness and reduced toxicity, compared with the
administration of unlabeled antibodies in combination with chemotherapy. Recent evidence has shown that
differentially labeled antibodies, i.e. labeled at different locations and with different numbers, can have distinct
therapeutic and pharmacokinetic properties and some subpopulations can show little, if any, therapeutic activity
yet account for most of the toxicity. Therefore, there has been a movement towards the development of site-
specific ADCs, which are precisely labeled with drugs at pre-defined locations.
We have recently developed two new approaches for the preparation of highly uniform ADCs, one site-specific
bioconjugation approach, Proximity-Based Sortase-mediated protein Ligation (PBS-PL), whereby sortase is
used to ligate drugs to a peptide tag that has been introduced into the antibody backbone, and one region-
specific bioconjugation approach, Proximity-based Sortase Isopeptide Ligation (PBS-IL), which allows for the
labeling of native antibodies with reduced variability compared with current lysine/cysteine residue labeling
approaches. Both methods produce ADCs in high yields, are compatible with glycosylated IgG, and offer
unlimited flexibility in antibody-drug linker chemistry. Therefore, we believe that these technologies will provide
new, favorable approaches for the production of ADCs that will be of interest to the pharmaceutical industry.
In this proposal, we have partnered with Integral Molecular and the University of Pennsylvania to develop
ADCs against claudin-18 (CLDN 18.2). CLD18.2 is ectopically expressed in several cancers including
pancreatic cancer, which is the focus of this proposal. Outcomes for pancreatic cancer patients are poor with a
5-year survival of <8% due to a lack of effective treatment modalities. Therefore, the development of new
therapies are a clinical necessity. The highly selective expression of CLDN18.2 in cancer, with no detectable
expression on any healthy adult tissues that are accessible to antibodies, make it an attractive option for
targeted therapy. We will prepare various ADCs using PBS-PL and PBS-IL and will identify the conjugation
approach and ADC formulation that is expected to be most favorable for clinical translation, based on serum
stability, pharmacokinetics, and efficacy. Pre-clinical testing will be performed in an orthotopic pancreatic tumor
model in syngeneic mice. The specific aims for the proposal are: Aim 1: Produce and characterize anti-
CLDN18.2-vcMMAE ADCs using PBS-PL and PBS-IL; Aim 2: Evaluate the binding and efficacy of anti-
CLDN18.2-vcMMAE ADCs in vitro; Aim 3. Determine the pharmacokinetics and efficacy of anti-CLDN18.2
ADCs in a murine tumor model

Public health relevance
The overall goal of this proposal is to utilize two unique bioconjugation technologies to produce highly homogeneous anti-CLDN18.2 antibody drug conjugates (ADC) for the treatment of pancreatic cancer and to identify the optimal approach and lead ADC for continued development into a clinical therapeutic.